Effect of methadone on the developmental properties of human brain organoids

ABSTRACT
The opioid crisis has become a national epidemic and the statistics are startling. In the past decade there
has been a sharp increase in heroin use, opiate prescriptions and fentanyl abuse. Overdose deaths have doubled
nationally since 2000 and in 2015, and more than 33,000 deaths were attributable to overdose from opioids. In
addition, there has been a major increase between 1998 and 2011 in the number of opioid-dependent pregnant
women, such as with methadone dependency. Although opioids have been well studied in general, the epidemic
of opioid abuse, especially in pregnant women, has unmasked how little we know about the effect of methadone
on fetal brain development. In the past several years, we have taken advantage of a newer technology, the 3D-
brain organoids, that facilitated enormously the investigation of early human brain development. This has provided
us with an unprecedented opportunity to investigate the cellular and molecular mechanisms underlying the effect
of opioids on early brain development. Using such methods, we have been able to produce exciting preliminary
data showing that methadone decreases synaptic transmission and possibly affects synaptic plasticity. Based on
our recent results, we have posed the following overall hypothesis: Opioid exposure leads to
abnormal synaptogenesis and impaired synaptic transmission during fetal brain development. In order to
address this hypothesis, we have formulated the following Specific Aims: Specific Aim 1: To determine the effect
of methadone on neural network activity during development in human cortical organoids. We will use multi-
electrode array recordings to explore how methadone modifies the neural network activity. Specific Aim 2: To
determine the effect of methadone on cellular electrophysiological properties and synaptic function and structure
during development in human cortical organoids. We will investigate AP firing properties, synaptic currents, and
Na+ and K+ currents in neurons and dissect the pre- and postsynaptic mechanisms using patch-clamp, molecular
and imaging techniques. Specific Aim 3: To dissect the mechanisms of the methadone-induced changes in
synaptogenesis and synaptic transmission in human cortical organoids. As thrombospondins 1,2 (TSP1,2),
astrocyte-secreted glycoproteins, play a role in neurite outgrowth, dendritic spine and synapse formation, we will
study the effect of methadone on TSPs to obtain an understanding of the molecular pathobiology of methadone’s
effect on the human fetal brain. Our studies in this application are novel and unique and address the important
problem of human brain maldevelopment under the influence of methadone in pregnant women. With an
understanding of the mechanisms involved in methadone effect, we believe that we can develop novel therapeutic
targets to mitigate the effect of methadone on brain development in early life.

Public health relevance
NARRATIVE Opioids have been abused enormously in our society in the past decade to the degree that it is at present an epidemic affecting our youth. In the current application, we focus on the effect of opioids, namely methadone, on the formation and development of the human brain in the fetus during pregnancy when pregnant women are using or abusing methadone. The idea behind this proposal is to be able to understand the mechanisms by which deleterious effects happen as a result of methadone use/abuse in order to counter them and mitigate the impairment induced by opioids on fetal brain integrity.